Post-transcriptional regulation of vascular homeostasis by RNA-binding proteins

PROJECT SUMMARY
Vascular homeostasis is essential for human health as endothelial cells (EC) perform important physiological
functions such as formation of vascular barriers. EC activation occurs when hypoxic or inflammatory signals lead
to EC sprouting, inflammatory gene expression, and vascular leakage, which disrupts vascular homeostasis and
causes vascular dysfunction and cardiovascular diseases. Therefore, this application focuses on identifying key
regulators of vascular homeostasis and understanding how they maintain normal vascular function, which forms
the basis for our long-term objectives to understand how the identified key homeostasis factors confer resilience
to the vasculature to prevent loss of vascular homeostasis in cardiovascular diseases. Here we focus on RNA-
binding proteins (RBP) as they are essential regulators of gene expression but highly understudied in vascular
biology. To identify key RBPs for maintenance of vascular homeostasis and suppression of EC activation, we
performed an in silico screen (single-cell RNAseq) followed by an in vitro screen, and identified the RBP
PABPC1, a critical polyA binding protein in cells, as a key suppressor of EC activation. To determine how
PABPC1 regulates vascular homeostasis, we generated induced EC-specific knockout (iECKO) mice of Pabpc1.
Within two weeks, these animals demonstrated robust EC activation and loss of vascular homeostasis
characterized by systemic inflammation, immune cell infiltration, and vascular leakage, culminating in death after
2-3 weeks. Mechanistically, PABPC1 depletion without inflammatory stimulus led to increased inflammatory
mRNAs in EC such as chemokines, suggesting that PABPC1 normally suppresses these mRNAs. PABPC1 likely
achieves the suppression through binding another RBP that is well-established to mediate decay of inflammatory
mRNAs. Based on our findings, we hypothesize that PABPC1 is required for suppression of EC activation and
maintenance of vascular homeostasis by regulating turnover of inflammatory mRNAs. We will test this hypothesis
with two aims: 1) determine if identified chemokine is a critical mediator of vascular phenotypes in Pabpc1iECKO
mice, and 2) define the molecular mechanism by which PABPC1 suppresses chemokine mRNAs in EC. We will
use single-cell RNAseq to investigate EC gene expression changes and EC-immune cell crosstalk in Pabpc1iECKO
mice. We will test if blocking of the identified chemokine rescues phenotypes in Pabpc1iECKO mice. We will also
use site-directed mutagenesis to test if PABPC1 binding to its RBP patterner is required for suppressing
inflammatory RNAs in EC. The proposal is conceptually innovative by suggesting an unexpected mechanistic
role of PABPC1 in maintaining vascular homeostasis by preventing EC activation through continuous
suppression of inflammatory mRNAs in EC. Since PABPC1 levels in EC decrease with aging and chronic
inflammation is a hallmark of aging, this mechanism is likely critical to age-related cardiovascular disease risk.
Our work will address whether PABPC1 and its downstream genes are potential drug targets to confer resilience
to the vasculature and prevent age-related cardiovascular diseases.

Public health relevance
PROJECT NARRATIVE Vascular homeostasis is essential for human health as endothelial cells (EC) perform important physiological functions such as formation of vascular barriers. Therefore, identifying key regulators of vascular homeostasis and understanding how they maintain normal vascular function is vital, and forms the basis for understanding how they contribute to disturbed vascular homeostasis in cardiovascular diseases. Our proposal will test the innovative hypothesis that the RNA binding protein PABPC1 plays an unexpected mechanistic role in maintaining vascular homeostasis by preventing EC activation and inflammation through continuous suppression of inflammatory mRNAs in EC, which will fill a major knowledge gap in vascular biology and address whether our identified PABPC1 and downstream genes are potential drug targets to confer resilience to the vasculature to prevent cardiovascular diseases.